IGF::OT::IGF Base Contract Title: Preclinical In Vitro and In Vivo Agent Development Assays, Task Order Title: A Polyvalent Vaccine Against Fusion Proteins Observed in Solid Tumors, Period of Perfo

This project will evaluate the potential of breakpoint vaccines for cancer prevention.